EARLY INTERVENTION FOR CHRONIC OBSTRUCTIVE PULMONARY DISEASE

This trial will test the efficacy of smoking cessation and bronchodilator therapy to prevent the development of chronic obstructive pulmonary disease (COPD) in cigarette smokers who have mild airflow obstruction.